The role of IL-6/STAT3 signaling in CIC-DUX4 fusion sarcoma metastasis and immunosuppression

ABSTRACT
CIC-DUX4 fusion-positive sarcomas (CDS) are an aggressive and understudied subset of small round cell
sarcomas that primarily affect children and adolescents/young adults. Due to a lack of mechanistic
understanding of how the CIC-DUX4 fusion oncoprotein drives CDS disease progression and metastasis,
patient outcomes remain dismal, and CDS is universally lethal in the metastatic setting. Therefore, there is an
urgent need to determine the mechanisms by which CIC-DUX4 fusion drives CDS metastasis. Our preliminary
data demonstrate that the CIC-DUX4 fusion oncoprotein activates IL-6/STAT3 signaling, leading to elevated
expression of cancer stem cell markers and reprogrammed lipid metabolism. Both cancer stem cells and
altered lipid metabolism have important role in tumor cell survival and metastasis in various cancers. In
addition to these tumor cell-intrinsic factors, during tumor growth in vivo, the CIC-DUX4 fusion mediates
dramatic recruitment of tumor-associated macrophages (TAMs), which produce multiple
immunosuppressive/metastatic chemokines and cytokines shown to be downstream of IL-6/STAT3 in other
cancers. Moreover, CIC-DUX4 fusion-expressing tumors show significantly increased Foxp3+PD1+CTLA4+
immunosuppressive CD4+ T cells. These findings suggest that the CIC-DUX4 fusion also facilitates CDS
tumor progression and metastasis through recruiting and regulating immune cells. Despite these findings, a
key remaining question is whether targeting IL-6/STAT3 signaling will effectively block CIC-DUX4 fusion
oncoprotein-driven tumor growth, metastasis, and immunosuppression. It is also unclear whether targeting IL-
6/STAT3 signaling can alleviate CICDUX4 fusion-induced immunosuppression to enable effective treatments
by immune checkpoint blockades. Therefore, we propose to define the critical role of IL-6/STAT3 signaling
intrinsic to tumor cells in CDS growth and metastasis, to define the dependency on IL- 6/STAT3 signaling in
CIC-DUX4-induced TAM recruitment and TAM-mediated immunosuppression and metastasis, and to
therapeutically exploit CIC-DUX4 fusion-mediated IL-6/STAT3 signaling-induced immunosuppression as a
prelude to a clinical trial. The mechanistic insights and information gained from the proposed studies will lead
to the development of a new rational therapy for this understudied patient population.

Public health relevance
We will define the underlying biological mechanisms by which IL-6/STAT3 signaling drives CIC- DUX4 fusion-mediated sarcoma progression/metastasis and immunosuppression. Through these mechanistic studies, our goals are to identify novel therapeutic targets to build the foundation for developing potent immune-based therapies that will improve outcomes for CIC-DUX4 fusion-positive patients.